Investigating the effects of psychosocial stress on laryngeal microbiology and epithelial barrier integrity

ABSTRACT
Biological mechanisms underlying psychosocial stress-induced changes to the larynx remain understudied.
Psychological stress symptomology is concurrently reported in 25% of patients with voice problems. From a
biological perspective, psychosocial stress can have deleterious consequences on both microbial communities
and epithelial barrier integrity, as reported, in other mucosal organs such as the gut and stomach. First, the
laryngeal microbiome has a distinct microbial composition when compared to the gut. How this distinct
composition is influenced by psychosocial stress remains unknown. Independently, stress-induced changes to
epithelial permeability (such as reduced epithelial proliferation and reduced mucus thickness) may potentially
leave the larynx susceptible to further infection. This proposal broadly questions whether psychosocial stress
can lead to microbial dysbiosis and compromised epithelial barrier integrity. In our proposed experiments, mice
will be assigned to unstressed or stressed groups. Psychosocial stress will be induced via a validated chronic
restraint stress protocol. Specific Aim 1 will determine laryngeal microbial adaptations following chronic,
psychosocial stress exposure. We hypothesize that psychosocial stress will result in reduced microbial
diversity and abundance, altered composition and differential abundance of specific bacterial taxa, and distinct
predicted functional profiles in the laryngeal microbiota. To obtain laryngeal microbiota outcomes, 16s rRNA
sequencing will be used completed on bacteria extracted from murine laryngeal tissue. Specific Aim 2 will
delineate changes in vocal fold epithelial integrity post-chronic psychosocial stress. We hypothesize
that psychosocial stress will result in increased bacterial translocation, decreased mucus thickness, reduced
epithelial proliferation, reduced epithelial cell junction integrity, and altered gene expression of mucins in the
vocal folds. Immunohistochemistry/ Immunofluorescence and qPCR will be used to delineate consequences of
psychosocial stress on the laryngeal epithelium. Taken together, we hypothesize that psychosocial stress will
concomitantly lead to microbial dysbiosis and alter epithelial barrier integrity in the larynx. Data from these two
aims will lay the groundwork for identifying and manipulating specific bacterial phyla to delineate host-microbial
epithelial interactions of psychosocial stress in the larynx.

Public health relevance
NARRATIVE Psychosocial stress and voice problems are inevitably linked, however, the underlying biological mechanisms governing this relationship remain understudied. The microbiome is a key regulator of the psychosocial stress response, with deleterious, stress-induced changes to epithelial barrier integrity. This proposal will investigate the microbial and epithelial consequences of psychosocial stress in the larynx.